DNA mechanotechnology to investigate the role of PD1 biophysics in T cell signaling

PROJECT SUMMARY/ABSTRACT
T cells survey the body for potential threats, including tumor cells, by probing their environment through physical
interactions. During these physical interactions, molecular forces generated by the T cell receptor (TCR) “pulling”
on potential threats help discriminate antigenic tissue from self-tissue by strengthening and prolonging TCR
bonds, thus causing an enhanced T cell activation signal. This is an intriguing concept, as a force pulling on a
molecular bond would be thought to cause rapid bond dissociation and loss of signaling. As this mechanical
force is critical for T cell activation and function, the role of molecular forces within the immune system should
be explored in other TCR co-receptor interactions as well. This includes the interaction between programmed
death receptor 1 (PD1) on T cells and programmed cell death ligand 1/2 (PDL1/2) on tumor cells; an interaction
that is revolutionizing cancer treatment but is currently still poorly understood. Specifically, it has been observed
that when an active T cell physically crawls on and engages a tumor cell expressing PDL1 or PDL2, the T cell
shuts down and loses its effector functions due to PD1 signaling, but through an unknown mechanism. As PD1
closely associates with the TCR, we hypothesize that the PD1 receptor is also force-regulated, and that
molecular-level mechanical forces are also critical to PD1 signaling. The goal of our research is to determine
the mechanistic role of mechanical forces in PD1 signaling, which we will accomplish through the following three
aims. Aim 1. Create and characterize recombinant PDL1/PDL2 force sensors to quantify PD1 forces in cytotoxic
T cells. Using molecular probes previously developed in our lab, we will design PDL1/2 force sensors that consist
of a hybridized DNA duplex functionalized with a fluorophore-quencher pair. Upon force application by the PD1
receptor, the DNA duplex is mechanically unfolded, causing separation of the fluorophore and quencher. This
increase in fluorescence can be mapped and quantified using conventional fluorescence microscopy, as the
DNA duplex can be tuned to display specific forces exerted by the receptors. The results of this study will allow
us to obtain the first maps of PD1 molecular forces in T cells. Aim 2. Determine the amino acids that contribute
to the mechanical stability of the PD1-PDL1/2 complex. We will use site-directed mutagenesis to generate a
mutant library of PDL1 and PDL2 to determine which amino acids contribute to molecular forces. Aim 3.
Determine the role of PD1 molecular forces in T cell signaling. We will mechanically cap the forces the PD1
receptor can transmit and relate this information to intracellular signaling. The results of these studies will
establish the role of PD1 mechanics in T cell signaling and will provide insight to the molecular events occurring
during the physical “kiss of death.” Understanding the paradigms of mechanical forces in T cell biology and tumor
recognition will greatly expand our knowledge of tumor-immune system interactions and will open doors to new
avenues of cancer immunotherapies.

Public health relevance
NARRATIVE Immune checkpoint inhibitors are becoming a first line therapy for cancer but have variable efficacy due to a lack of fully understanding their mechanism of action. We will explore the biophysical and mechanical components of their mechanism of action on immune cells to further understand these therapies. This project will advance our understanding of mechanical forces in immune checkpoint receptors and provide the applicant with critical skills for a career in immunoengineering.